Adaptation of Path-Pain for Older Hispanics Living with Chronic Pain and Depression

Summary of the parent grant.
Over the past 25 years, Cornell's Roybal Center, the Translational Research Institute on Pain in Later Life
(TRIPLL), has developed innovative approaches and an effective infrastructure to support the translation of
behavioral and social science research into practices that improve the health and well-being of older adults. Over
the past 12 years, TRIPLL has focused on the development, testing and dissemination of evidence-base
interventions for older adults suffering from various pain disorders. TRIPLL was created to maximize the joint
resources for aging-related research at Cornell University, uniting social and behavioral scientists and experts
in translational research at Cornell's Ithaca campus with clinical researchers at Cornell's medical college in New
York City. The specific aims of TRIPLL are to: 1) translate the findings of behavior-change science into novel
interventions for older adults with pain; 2) maintain a vibrant investigator-development program that engages
new researchers in applying behavior-change theories to maximize adaptive aging; 3) provide an effective
infrastructure for translating behavior-change research; and 4) leverage the intellectual, fiscal, and other
resources of the academic collaborators in this application, thereby achieving results that would not be attainable
by any one institution alone.

Public health relevance
Project Narrative - Overall Pain is highly prevalent, costly, and frequently disabling in older adults. Behavioral interventions such as psychological therapies and exercise programs are now routinely encouraged as primary treatments for pain, but research is needed to enhance their efficacy, effectiveness and long-term benefits. This proposal seeks to develop potent and scalable behavioral interventions to address the problem of later-life pain using the NIH Stage Model to guide intervention development and progression along the translational continuum.